GROWTH OF NON STARTER LACTIC ACID BACTERIA IN REDUCED FAT CHEESE

This study is designed to investigate the catabolism of methionine in lactic acid bacteria to produce methanethiol. Two pathways are involved in the catabolism: 1) α,γ-elimination by cystothionine β-lyase and 2) transamination. 13C NMR using the DMX 400 MHz spectrometer should yield a way to differentiate between the two pathways as well a the possible distribution between the two pathways.